Project 4: Tumorigenic Effects of Tax

PROJECT SUMMARY HTLV-1 is the etiological agent of adult T-cell leukemia lymphoma (ATLL). ATLL cells are characterized by constitutive NFκB activation, a key feature of other lymphomas, myeloma, and solid tumors. The Tax oncoprotein is the key viral determinant for NFκB activation. Our previous studies showed that the classical and especially, the alternative NFκB pathways were critical in conferring resistance to apoptosis. Our primary hypothesis is that Tax activation of NFκB is critical for tumorigenesis, particularly the alternative (alt) NFκB pathway. The current study will use innovative, physiological lymphoma models to define the role in tumorigenesis of each NFκB pathway and identify the key regulators of the NFκB pathway. Aim 1. Aim 1. To assess the role of alt NFκB activity in Tax-mediated transformation A new humanized mouse model is used for HTLV-1 infection and lymphoma development. We will use viral variants expressing Tax mutants with defects in activating the alternative NFκB pathway or both NFκB pathways, in order to define their role in disease pathogenesis. A novel high-throughput viral integration assay is used to monitor clonality of infected cells in these experiments. Aim 2. To identify and characterize Tax interactive proteins that mediate alt NFκB activation We will identify Tax interactive proteins that mediate alt NFκB pathway activation. Proteins that interact with wild type but not mutant Tax will then be characterized using shRNAs to assess their effect on Tax induced cleavage of alt NFκB precursor protein, p100, as well as effects on proliferation and apoptosis of HTLV-1 transformed cells in culture and immunodeficient mice. It is expected that the information these physiologically relevant mouse models will identify key target genes that may be inhibited in therapeutic trials of ATLL or other lymphomas.

Public health relevance
HTLV-1 causes an aggressive form of leukemia/lymphoma. The Tax protein is critical for tumor initiation. Tax activation of gene expression through the nuclear kappa B (NFκB) pathway is responsible for the ability of these tumor cells to avoid cell death. The current project examines the role of the “alternative” NFκB pathway in the ability of HTLV-1 to cause tumors in mice reconstituted with human lymphoid cells. In addition, this project uncovers the molecular mechanism whereby Tax activates the alternative NFκB pathway. These studies are likely to identify new targets for treatment or prevention of leukemia/lymphoma caused by HTLV-1, or other agents that utilize the alternative NFκB pathway in causing cancer.